Using Implementation Science to Advance Evidence-Based Treatment for Stimulant Use

PROJECT SUMMARY
This K01 award is designed to provide Dr. Erath with mentored training in implementation science to
become an independent investigator focused on advancing the implementation of evidence-based treatments
for stimulant use disorder (StimUD) and other substance use disorders (SUDs) in harm reduction and other
community treatment and recovery settings. The training objectives of this application are threefold: (1) gain
proficiency in implementation science theory and research methodology through formal course work, (2) obtain
hands-on experiential learning by observing and participating in a seminal statewide implementation of
contingency management (CM) treatment for StimUD in California, and (3) develop professional repertoires
necessary to be a successful implementation scientist leading an independent research program. Dr. Erath’s
multidisciplinary mentorship team is comprised of four nationally recognized independent investigators (Drs.
Stephen T. Higgins, Richard A. Rawson, Sara J. Becker, and Kimber P. Richter) with expertise in treatment
development for StimUD and other SUDs, implementation science, mentoring early-career investigators, and a
successful record of obtaining federal research funding. The proposed research plan seeks to develop hands-
on experience and skills in implementation science advancing the use of CM, an evidence-based treatment for
StimUD, in community harm-reduction settings using syringe service programs (SSPs) as a model. Despite
decades of studies supporting CM’s efficacy for StimUD, its use in community settings is surprisingly limited.
To help address this gap, the research plan has three specific aims: (1) conduct a qualitative study examining
contextual determinants of implementing CM for StimUD in community SSPs, (2) develop a theory- and
partner-informed set of implementation strategies to promote the use and sustainment of CM for StimUD in
community SSPs, and (3) conduct a hybrid type 2 pilot feasibility study that simultaneously evaluates the
potential efficacy of CM for StimUD in two SSPs and the efficacy of the partner-informed implementation
strategies. The proposed research is innovative because it represents a substantial departure from the status
quo by examining implementation of CM for StimUD in low-barrier harm reduction settings—an emerging and
promising setting for SUD treatment. Moreover, the completion of these three aims is significant because it will
help address a notable evidence-to-practice gap on the use of a highly effective StimUD treatment in practice,
and create a working model, grounded in implementation science, for how to implement CM for StimUD in
SSPs that could be adapted and advanced by future research. Overall, this K01 award is designed to provide
the requisite training and research experience necessary to become a successful implementation scientist,
using the obtained knowledge and preliminary findings to open new horizons in advancing the implementation
of evidence-based treatments for StimUD and other SUDs in community-based harm reduction and other
addiction treatment and recovery settings.

Public health relevance
The overarching aim of this K01 award is for Dr. Erath to obtain mentored training in implementation science to become an independent investigator advancing the use of evidence-based treatment for stimulant use disorder (StimUD) and other substance use disorders (SUD) in harm reduction and other community settings. The training proposal includes (1) formal coursework in implementation science, (2) expert mentorship and hands- on learning in implementation science and StimUD treatment development, and (3) leading original implementation science research. The goal of this research is to generate new knowledge and strategies to advance the implementation of contingency management, an evidence-based treatment for StimUD, in community settings and extend its use to the unstudied, potential treatment setting of syringe service programs.